Phase 2 COVID-19 Vaccine Variant Clinical Trial

To support a Phase 2 clinical trial evaluating various additional COVID-19 booster shots, the COVID-19 Variant Immunologic Landscape (COVAIL) clinical trial.